Creation of a Trusted Data Broker, Development of a Data Access Platform and Design of a Public Private Partnership to Implement the NIH's Data COUNTS Program for Access to Quality Data.

Data COUNTS Trusted Data Broker
Abstract for FNIH OT Proposal
Creation of Trusted Data Broker to Implement Data COUNTS Program
September 16, 2024
The Data Collect Once Use Numerous TimeS (Data COUNTS) initiative will facilitate better data access to
address health outcomes, eliminate costly and burdensome data collection processes, and improve the
quality and speed of time-to-access data. The intent of Data COUNTS is to deliver a federated electronic health
record (EHR) and health data collection and transmission architecture based on open-industry data and
interoperability standards for HHS. The FNIH will use its extensive experience designing, soliciting, and
managing complex data infrastructures and public-private partnerships in the health sciences ﬁeld to establish
a Trusted Data Broker (TDB). The TBD will establish a secure, cloud-based platform for quality-controlled data
collection, transmission, and analysis. The TDB will establish the necessary relationships and governing bodies
to coordinate activities across all stakeholders, from data ingestion to analysis. The system will use extensive
provenance and data lineage tracking and a robust data model to enable HHS researchers to interrogate
patient data in novel ways. The FNIH is committed to meeting the goals of the Data COUNTS initiative and
revolutionizing health science capabilities, addressing a critical gap in the United States’ ability to advance
biomedical sciences compared to other industrial nations. Patient engagement and trust will be central
features of all activities, and the system will be designed and implemented with the eventual goal to empower
patients with full control and transparency over how their data are accessed and used. The ﬁrst year of the
project will focus on (1) design and implementation of a phased strategic plan for creation of the TDB, (2)
creation of an engagement strategy and a management strategy, and (3) securing technical contractor(s) to
design and deliver a minimal viable product to execute HHS-deﬁned use cases. Activities in the ﬁrst year will
lay the foundation for sustainable and scalable development in the future.

Public health relevance
Data COUNTS Trusted Data Broker Public Health Relevance for FNIH OT Creation of Trusted Data Broker to Implement Data COUNTS Program May 11, 2026 To help address the growing chronic disease crisis in America, the NIH intends to establish a Real-World Data Network (RWDN) to assist researchers studying predisposing factors, prevention strategies, treatment options, and the long-term consequences of chronic diseases. Real-world data (https://www.fda.gov/science-research/science-and-research-special-topics/real-world-evidence)  are data relating to patient health status and/or the delivery of health care routinely collected from a variety of sources. The Data Collect Once Use Numerous TimeS (COUNTS) Trusted Data Broker (TDB) supports this RWDN vision by enabling secure, governed access to high-quality patient health data across participating institutions. Through a “collect once, use numerous times” model, the TDB reduces duplication, lowers access barriers, and improves the quality and timeliness of data, with provenance and traceability supporting transparency, reproducibility, and trust. This capability strengthens public health by enabling timely and reliable analysis of disease patterns, treatment effectiveness, and long-term outcomes. It supports clinical decision-making, enhances disease surveillance, and enables evaluation of prevention and intervention strategies across HHS, contributing to improved health outcomes. Together, NIH’s RWDN and the Data COUNTS TDB will advance a national learning health system and improve the ability of clinicians, researchers, and public health stakeholders to generate actionable insights that improve health outcomes nationwide.